Discovery and Development of Organic Reactions Catalyzed by Transition Metals Valuable for Medicinal Chemistry

Project Summary
We are requesting administrative equipment supplemental funds to acquire a preparative HPLC that allows for
automated purifications of materials that are difficult to separate by flash column chromatography. This
instrument will significantly increase productivity and workflow towards the parent goals of R35GM130387 by
enabling rapid purification of crude reactions containing non-volatile products from catalytic reactions on complex
molecules. Currently, our research group does not have access to preparative HPLC, let alone preparative
systems with the software that allows automated transfer of conditions from analytical to preparative HPLC. A
major current focus of researchers studying catalytic reactions, including those of the PI’s laboratory, is to create
systems that introduce new functional groups in complex molecules with high selectivity. Multiple projects
supported by the PI’s current NIH funding address this general goal and would benefit from this new capability
in our group. These include the regioselective borylation, silylation, and alkylation of (sp3)C-H bonds in natural
products and complex molecules from medicinal chemistry, the selective oxidation and subsequent derivatization
of complex terpenes, and reactions catalyzed by artificial metalloenzymes, including reactions in whole cells.
With a method to rapidly purify the products of these reactions, the isomers of the product formed can be
identified, and progress on these research goals will be greatly accelerated.

Public health relevance
Project Narrative A preparative HPLC comprising an ultra-high-pressure LC unit and automated collection will be used to significantly increase productivity and workflow towards the parent goals of R35GM130387, including the development of catalysts and catalytic reactions that modify or introduce functional groups site-selectively in complex molecules relevant to human health. The preparative HPLC is requested to enable rapid separation of constitutional isomers and stereoisomers of reactions involving non-volatile reactants and products, predominantly those generated by the functionalization of C–H bonds.